HSOD TURN MUTANT &PERMUTANT STRUCTURES TO STUDY GREEK KEY B BARRELS: ALS

Mutations in key structural residues of the HSOD b-barrel can lead to the lethal neurodegenerative disease amyotrophic lateral sclerosis in heterozygous human patients. We want to investigate the folding properties of Greek key b-barrels and determine the structures of HSOD mutant and permutant.